Molecular strategies for early detection and targeting of cancer

Summary
Cancer progression and relapse remain the reality of current cancer therapy. Our work is aimed at understanding
the root causes of this persistent problem. Since my lab’s inception we have probed the role of developmental
signals in cancer initiation and propagation, used imaging to discover new programs that control cancer
progression, and carried out preclinical work that has formed the basis of clinical trials testing new agents for
drug-resistant leukemias – leading to the recent approval of Glasdegib to treat aggressive leukemia – and
pancreatic cancer. The current work I describe shows that the paradigm we established for hematologic
malignancies is a remarkably general principle used repeatedly in the regulation of many deadly cancers
including pancreatic cancer. Our prior studies have collectively set the stage for new avenues of research we
will pursue over the course of the next few years. In particular we plan to: 1) Define how differentiated benign
lesions transition to aggressive undifferentiated malignancies and develop targeting strategies; 2) Understand
cancer heterogeneity and define intrinsic and micro-environmental mechanisms that support therapy resistant
cells; 3) Trace the origins and evolution of distinct subtypes of pancreatic cancer; and 4) Identify new strategies
for early detection and early interception in pancreatic cancer. Collectively, these studies will provide a deeper
understanding of key challenges in cancer biology, including early detection, drug resistance and disease
recurrence, and will identify new targets and approaches to therapy that may lead to significantly improved
patient outcomes.

Public health relevance
Narrative The primary focus of my work has been to understand the mechanisms by which cancers subvert normal developmental and stem cell signals to grow, spread and evade therapy. Over the last decade our work has ranged from discovery of new signals involved in cancer growth and progression to preclinical work that has formed the basis of clinical trials testing new agents for drug-resistant leukemias – leading to the recent approval of Glasdegib to treat aggressive leukemia – and pancreatic cancer. In the coming years, we will continue to strive to make important contributions that will have a meaningful impact on the many lives that deeply depend on the discoveries we make as a community.